DOE Career Paths through Partnerships, Apprenticeship, and Training

With over 55 years of workforce development experience, LIUNA Training and Education Fund (LIUNA Training) will provide Construction Craft Laborer (CCLs) apprentices and journey-workers at Department of Energy (DOE) facilities with training to: (1) identify job site hazards to protect workers, communities and the environment; (2) prepare for unanticipated job site incidents; (3) support disaster response actions; and (4) build an ongoing culture of safety. As a DOE grantee since 1994, LIUNA Training will continue to train for the unique job conditions, and known, new and unknown hazards and threats facing nuclear sites. The goal remains to provide a broad range of skills and knowledge; reduce and eliminate job site accidents, injuries, and fatalities; increase reciprocity across facilities; and meet required government regulations.
LIUNA Training and our affiliated training centers will meet the training and certification needs of CCLs, other trade workers, contractor personnel, and DOE staff. LIUNA Training will utilize partnerships and subject matter expert collaboration to improve and deliver quality assurance, correct health and safety issues, incorporate scientific and technological advances, and share model program successes. Conducted outreach and program acceptance will be open to all qualified individuals. LIUNA Training will provide training on waste containment, reduction, and removal; building demolition, construction and/or reconstruction and renovation; radiation monitoring and decommissioning, as well as requested classes for DOE personnel. Additionally, it will expand the number of courses receiving reciprocity across the DOE complexes. To date, LIUNA Training offers more than 3 dozen environmental, safety and construction related courses for workers, supervisors, and DOE personnel, with 20 of these courses having DOE reciprocity.
LIUNA Training’s affiliated subgrantees will provide training at DOE sites in the following states: Idaho, Kentucky, Nevada, New Mexico, New York, Oregon, South Carolina, Tennessee, and Washington. LIUNA Training will also provide on-demand training for identified needs at other DOE facilities. In total, LIUNA Training proposes approximately 126 training weeks for 3,661 trainees during Year 1 and similar levels during Years 2-5. LIUNA Training will continue its tradition of utilizing trained and certified instructors, provide competency-based credentials, and foster effective educational and training models including use of new technologies. Collaborative efforts with the DOE National Training Center, industry, and workforce development organizations will help advance training innovations and improve overall quality and effectiveness of the DOE Worker Training Program at large.

Public health relevance
As one of the original WTP grantees in 1987, LIUNA Training brings to this proposal 37 years of exemplary, successful, innovative grant performance under Departments of Energy, Labor and Education, OSHA, EPA and NIEHS grants with each showcasing positive results and the capacity of our 62+ labor-management training centers from across the U.S. and Puerto Rico. In partnership with this high performing network that routinely delivers quality training and certification programs to approximately 500,000 Construction Craft Laborer (CCLs), pre-apprentices, apprentices, and journey-workers, LIUNA Training leverages over 55 years of workforce development expertise and 30 years of providing cutting edge, accredited training and educational products and programs that directly support DOE performance, from closures and site operations, to training of hundreds of thousands of workers, law enforcement agents, SWAT Team members, U.S. Marshal staff, Capital police, and U.S. National Park Police, and hazardous waste and radiation training for a variety of DOE staff to continue offering the highest level of radiological, nuclear, construction, demolition and safety training in the industry. Building upon its strong relationship with DOE’s National Training Center and training managers, LIUNA Training will (1) implement curriculum and training programs to meet DOE needs; (2) continue to provide timely training through regular and on-demand formats; and (3) expand its catalogue of courses that have DOE reciprocity.